Characterizing proteasome-substrate interactions by mass spectrometry proteomics

PROJECT SUMMARY
This application features a close collaboration between bioanalytical (Dr. Reilly, Indiana University) and bio-
chemistry (Dr. Matouschek, University of Texas, Austin) research groups aimed at improving our understanding
of the ubiquitin-proteasome protein degradation system. The investigators contribute complementary expertise
and experience in a variety of disciplines ranging from proteomics, protein bioinformatics, analytical chemistry
and instrumentation, to biochemistry, molecular biology and cell biology. At Indiana University, cross-linking
mass spectrometry will be combined with biochemical and genetic assays to characterize the interaction between
the proteasome and its substrates to provide candidates for novel substrate receptors on the proteasome. At
The University of Texas at Austin, the biological relevance of candidates will then be tested in biochemical pro-
teasome assays and genetic yeast experiments. These assays will define the contribution of newly identified
components to substrate recognition and degradation by the proteasome and elucidate the molecular and struc-
tural origin of substrate selection and specificity.
Overall, we believe that this proposal will result in significant advances in cross-linking methodology and in our
understanding of how the proteasome recognizes and digests substrates.

Public health relevance
Project Narrative: The maintenance of proteostasis is crucial for resistance to disease and healthy aging. One of the key elements of proteostasis is protein degradation. This project aims to improve our understanding of how ubiquitin, protein substrates and the proteasome interact so as to degrade proteins.